Administrative Core

The Administrative Core will coordinate the overall interactions among the two projects and scientific core facilities of the proposal. The Core leadership will provide oversight to the program project, administer the projects and scientific core, and promote collaboration within the group and across the Steering Committee through the following specific aims: 1) We provide the general administrative infrastructure in budgeting, purchasing, administration and reporting necessary to run a complex program project grant;2) We provide specialized expertise in various matters such as animal use regulatory issues, to allow the project investigators to pursue their programs within the scope of current regulations and technology;3) We promote collaboration among the program project through the coordination of meetings to present ongoing research; and 4) We coordinate participation in Steering Committee meetings and other NHPCSG activities.